Defining the relationship between titin segment A168-170 and the E3 ligase MuRF1 in skeletal muscle atrophy

Abstract
Skeletal muscle plasticity is highly dependent on load, and muscles quickly atrophy under many conditions
including disuse, systemic disease, aging, etc., causing drastic consequences for quality of life. Muscle wasting
and weakness is caused by disassembly of the sarcomere, the basic contractile structure of muscle. The
myofilament titin contains spring-like regions and multiple sites for signaling protein binding, making it a
sentinel for changes in muscle load. Titin’s A-band to M-line transition contains an E3 ligase binding site
(domains A168-170) adjacent to its mechanosensitive pseudokinase domain (TK). E3 ligases ubiquitinate
proteins to target them for degradation, making them important members of the muscle atrophy program. The
E3 ligase MuRF1 (TRIM63) is termed an “atrogene” for its propensity to be upregulated in the early stages of
muscle atrophy. In vivo overexpression of MuRF1 in the absence of unloading causes muscle wasting at the
muscle weight and fiber CSA levels. In vitro experiments have shown that overexpressed MuRF1 colocalizes
with the A168-TK segment and causes loss of M-line and thick filament structure. Furthermore, in vitro and in
vivo studies show that MuRF1 heavily ubiquitinates titin during atrophy, such that titin is MuRF1’s most highly
ubiquitinated substrate. Myomesin and myosin heavy chain are also ubiquitinated by MuRF1, and several thick
filament protein components are degraded in a MuRF1-dependent manner during atrophy. The overall goal of
this proposal is to decipher the role of titin segment A168-170 and MuRF1 during muscle atrophy, and my
overarching hypothesis is that the interaction of MuRF1 and titin A168-170 is important for initiating atrophy by
promoting M-line and thick filament disassembly. Toward this end, I generated a mouse model,
TtnA168-170→I104-106, in which titin’s E3-binding domains A168-170 are “substituted” with three titin domains lacking
an E3 binding site, I104-106. I opted for this novel “substitution” model to preserve general titin structure while
preventing MuRF1 (and other E3s) from binding. My preliminary data indicates that titin incorporation and
expression are preserved in this mouse model, but that localization of overexpressed MuRF1 at the M-line is
lost. To test my hypothesis, I will subject control (WT) and TtnA168-170→I104-106 “substitution” mice to two atrophy
models: 1) MuRF1 overexpression via AAV9: CMV-MuRF1-Spot tag, and 2) sciatic nerve transection. I will
critically analyze the response of both genotypes based on ubiquitin remnant-enriched quantitative proteomics,
muscle structural features, and levels of autophagy- and proteasome-linked proteins and myofilament proteins
in fractionated (sarcoplasmic vs. myofibrillar) muscle. Upon completion of this project, I will have established
the role of the interaction between titin A168-170 and MuRF1 in initiating sarcomere disassembly during
atrophy states, which will indicate if the titin-MuRF1 interaction is a viable therapeutic target.

Public health relevance
Project Narrative Skeletal muscle atrophy is a condition in which muscles weaken and waste, caused by aging, systemic disease, disuse, etc. Titin’s E3 ligase-binding segment, domains A168-A170, interacts with the atrophy-linked E3 ligase MuRF1, and their interaction is proposed to be important for the induction of muscle atrophy through targeting of sarcomere proteins for degradation. The proposed work will determine the role of titin-MuRF1 signaling in the induction of sarcomere disassembly, with the potential to reveal a target for modulating atrophy in patients.